Androgen effects on the reproductive neuroendocrine axis

PROJECT SUMMARY
This R01 proposal responds to “Notice of Special Interest in Research on the Health of Sexual and Gender
Minority (SGM) Populations” (NOT-MD-19-001) which calls for research describing “clinical, behavioral, and
social processes affecting the health of SGM individuals and their families” that will promote development of
appropriate interventions to improve SGM health and fertility care. This proposal includes clinical studies of
transgender individuals and the effects of androgen treatment on their reproductive health. Androgens can have
significant inhibitory effects on neuroendocrine reproductive hormone secretion in both sexes, yet the
mechanisms and cell types by which androgens suppress GnRH and LH pulsatile and surge secretion in females
are poorly studied and remain unknown. Indeed, high levels of exogenous androgens fundamentally contribute
to reproductive disruption seen in otherwise healthy women and transgender men (female sex individuals taking
high levels of androgens), but the mechanisms, time course, and target neuroendocrine site(s) of action for these
inhibitory androgen effects are poorly understood. Our overall hypothesis is that male levels of exogenous
androgens can inhibit the female reproductive neuroendocrine axis by acting through androgen receptor (AR) in
hypothalamic kisspeptin neurons to modulate endogenous LH pulse secretion and impede generation of the
estrogen-generated preovulatory LH surge. We test this hypothesis in two complementary Aims that study the
role of high exogenous androgens in both a clinical setting in transgender male (female sex) human subjects
and corresponding transgenic female mouse models. Aim 1 investigates the effects of exogenous androgens in
a clinical setting, studying transgender men taking gender affirming testosterone therapy. This clinical Aim
assess the inhibitory effects and time-course of androgen treatment on a wide suite of reproductive
neuroendocrine parameters, with a focus on in vivo LH pulse and LH surge secretion, coupled with analyses of
menstrual cyclicity and ovarian measures. Aim 2 utilizes transgenic mice to test whether male-level androgens
acting via AR specifically in kisspeptin neurons are necessary and/or sufficient for androgen inhibition of in vivo
LH pulse parameters, including pulse frequency, and the estrogen-induced LH surge. This Aim also elucidates
whether elevated androgen action directly in kisspeptin cells is necessary for AR inhibition of reproductive gene
expression in the female brain, and uses innovative methodology to analyze androgen-induced changes in the
transcriptome of specific kisspeptin neural populations in females, identifying how exogenous androgens impact
these neurons to impede LH secretion. Together, these two complementary Aims will elucidate the cellular,
molecular, and physiological mechanisms of androgen inhibition on female neuroendocrine reproductive
hormones. This project will advance our understanding of fundamental mechanisms of androgen action in
neuroendocrine control of reproduction and inform upon future clinical interventions for rescuing reproductive
function in females or currently understudied SGM transgender males exposed to exogenous androgens.

Public health relevance
NARRATIVE High levels of circulating androgens can negatively affect neuroendocrine reproductive hormone levels in females, yet the mechanisms and target cells by which androgens achieve these effects remain unknown. Indeed, hyperandrogenemia from exogenous androgens is a fundamental aspect of reproductive disruptions seen in transgender men (genetic females) and other clinical conditions, but little is known about how such disruptions are incurred. This proposal will utilize cutting edge molecular, genetic, and physiological techniques coupled with experiments in both genetic mouse models and human transgender subjects to delineate the specific cell targets and physiological mechanisms by which androgens can impact normal female reproductive hormone secretion and will improve understanding of androgen inhibition of neuroendocrine reproductive dysfunction.